Neuroplastic Mechanisms for Acquisition and Transfer of Injury-Resistant Movement Patterns Assessed in VR Simulated Sport

Project Summary/Abstract
Anterior cruciate ligament (ACL) injury is a common activity-related knee injury with a substantial negative impact
on individuals and society. Annual direct costs exceed $13 billion, and the long-term indirect costs far exceed
that figure, as ACL injury is also linked to the accelerated development of disabling osteoarthritis within a few
years after injury. The National Public Health Agenda for Osteoarthritis recommends expanding and enhancing
evidence-based ACL injury prevention to reduce this burden. We have identified modifiable movement patterns
that increase ACL injury risk in young female athletes. While neuromuscular training targets those injury risk
movement patterns and shows statistical efficacy in high-risk athletes, a meaningful transfer of low-risk
mechanics to the field of play has been limited. This inability of current approaches to ensure injury-resistant
movement pattern transfer to sport is readily apparent as there has not been a decrease in national ACL injury
rates in young female athlete despite efficacy of standard neuromuscular training to modify biomechanics in the
lab. The key knowledge gap to ensure effective injury prevention transfer to sport is understanding the
mechanisms the nervous system engages to acquire and transfer injury-resistant movement patterns from the
intervention or laboratory to the athletic field. Thus, the overall objective of this proposal is to determine the
neural mechanisms underpinning the transfer of injury-resistant movement patterns to realistic sport scenarios.
Our published and recent preliminary data on the neuroplasticity related to injury risk and following
neuromuscular training demonstrate a specific neural mechanism underlies the transfer of injury-resistant
movement patterns. These preliminary data support this proposal's central hypothesis that changes in brain
activity underlie the acquisition and transfer of injury-resistant movement patterns to realistic sport scenarios.
Importantly this work indicates the neuroplasticity can be targeted by augmented biofeedback and other clinical
methods to optimize brain activation patterns for movement that promote injury-resistant movement pattern
acquisition and transfer. The ability to target the neural mechanisms of injury risk factor reduction could
revolutionize ACL injury prevention strategies. Once the objectives of this application are achieved, we will be
able to enhance the efficacy of neuromuscular training with the identified neuro-therapeutic targets. This
contribution will be significant to improve ACL injury prevention training transferability to reduce injury incidence
and thus avoid the associated long-term negative health consequences. This is especially relevant to young
female athletes as they are the population at highest risk for non-contact sensorimotor error related ACL injury.
This unique opportunity to enhance ACL injury prevention by targeting neural mechanisms of neuromuscular
adaptation and transfer highlights the exceptional opportunity afforded by this ancillary project to the parent U01
NIH investment.

Public health relevance
Project Narrative The proposed research is relevant to public health because musculoskeletal injuries in youth and adolescents contribute to the onset of disabling osteoarthritis and substantially reduced quality of life. Our proposal to discover the neural mechanisms for injury-resistant movement pattern acquisition and transfer will lead to enhanced interventions that allow more children' and adults to lead a healthy and active lifestyle. The project is relevant to NIH's mission to enhance health and reduce disability as the newly obtained knowledge will optimize injury prevention strategies through innovative biofeedback and other technology breakthroughs.